CE25-149 - The effect of Medicaid expansion on medications for opioid use disorder, mental health care, and overdose mortality among formerly incarcerated people

PROJECT SUMMARY/ABSTRACT
People involved in the criminal legal system (CLS) face a disproportionately high burden of substance and
opioid use disorders (SUD/OUD), which upon release from jail or prison is compounded by lack of access to
care and results in extremely elevated post-release drug overdose mortality. Few interventions have been able
to reduce overdose risk among CLS-involved people. A number of ongoing studies are testing strategies for
linking CLS-involved people to medications for OUD (MOUD) in the community. However, lack of insurance for
many CLS-involved people makes these care linkages unsustainable after study completion.
Medicaid expansion provides an avenue to address healthcare needs for many CLS-involved people.
Recent studies show that pre-release Medicaid enrollment increases post-release MOUD and reduces
overdoses for CLS-involved people. However, benefits appear to accrue to white individuals and not to black
individuals – a concerning inequity because overdose deaths are rapidly increasing among racially minoritized
people in the US. Research to date, which has been ecological, has not been able to identify the mechanisms
by which Medicaid enrollment may improve MOUD and overdose outcomes and why these benefits may differ
across racialized groups. Large, longitudinal, individual level data can map the pathways through which
Medicaid expansion benefits some groups but not others.
While overdose prevention work among CLS-involved people deservedly focuses on MOUD access, the
role of mental health treatment is also critical. Two-thirds of people with OUD have co-occurring mental health
needs, a burden that is likely even higher among CLS-involved individuals. Hence, MOUD without mental
health care may fall short in MOUD engagement and overdose prevention for CLS-involved individuals.
In this application, we propose to conduct a quasi-experimental study, by leveraging the 2023 Medicaid
expansion in North Carolina (NC), to examine racialized inequities in enrollment in Medicaid among CLS-
involved individuals, as well as post-release MOUD and mental health care access. We will further examine
the impact of enrollment in Medicaid and MOUD and mental health care access on fatal and non-fatal drug and
opioid overdoses. We will use 13 years of Big Data (2013-2025) on all formerly incarcerated people in NC
linked with Medicaid and death records, which our team already has access to through two ongoing studies
focused on suicide and polydrug overdose prevention. Our study is aligned with RFA-CE-25-149’s Funding
Option A. This study will be the first to examine the individual-level impact of Medicaid enrollment, MOUD
access, and mental health services on drug and opioid overdoses among CLS-involved people. This study will
further identify mechanistic factors that contribute to racialized inequities among CLS-involved people to help
enhance and sustain linkage to care for all CLS-involved people, but especially racially minoritized individuals,
thereby enhancing the impact of Medicaid expansion for all people.

Public health relevance
PROJECT NARRATIVE This study will be the first to examine the individual-level impact of Medicaid enrollment, MOUD access, and mental health services on drug and opioid overdoses among criminal legal system (CLS)-involved people and differences in benefits across racialized groups. We will combine 13 years of comprehensive individual- level data on CLS-involved individuals, Medicaid enrollees, and mortality records from NC and will innovatively leverage NC’s recent Medicaid expansion in a robust quasi-experimental design. Overall, this study will identify mechanistic factors that contribute to racialized inequities among CLS-involved people to help enhance and sustain linkage to MOUD and mental health care for all CLS-involved people, and especially racially minoritized individuals.